COVID-19 Supplemental work: NON-HUMAN PRIMATE MAJOR HISTOCOMPATIBILITY COMPLEX ALLELE DISCOVERY AND TYPING TECHNOLOGY DEVELOPMENT.

The study will validate a NGS-based COVID-19 detection system for unambiguous sequence-based reporting using residual materials / isolated total nucleic acids remaining after a RT-PCR based COVID-19 testing is performed.